OFC Astrocytes and Ethanol

PROJECT SUMMARY
Alcohol use disorder (AUD) is characterized by the progression from recreational drinking to uncontrollable and
excessive consumption resulting in myriad of social and neurobiological complications. While the mechanisms
underlying the dependence-induced escalation in drinking are not completely understood, a key brain region
disrupted in individuals with AUD is the orbitofrontal cortex (OFC). Previous studies from the Woodward
laboratory showed that acute ethanol inhibits action potential firing of lateral orbitofrontal (lOFC) cortex pyramidal
neurons via activation of astrocytic D1/D5 dopamine receptors, depolarization of the astrocyte membrane
potential and the release of glycine via reversal of the astrocytic GlyT1 glycine transporter. Following chronic
intermittent exposure (CIE) to alcohol, lOFC neurons become hyperexcitable and are tolerant to acute ethanol.
Although our work has defined how acute and chronic ethanol alter lOFC neuron excitability, there is virtually
nothing known about the effects of CIE exposure on lOFC astrocytes and how this contributes to changes in
lOFC neuronal excitability. The overarching goal of this proposal is to address this major shortcoming in our
knowledge by identifying CIE-induced changes in lOFC astrocyte physiology, structure and gene expression and
test whether these changes contribute to the excessive drinking observed in alcohol-dependence. To accomplish
this goal, studies in Aim 1 of this proposal use ex vivo slice electrophysiology and calcium imaging approaches
complemented by in vivo fiber photometry measures of astrocyte calcium signaling following repeated cycles of
CIE exposure. Aim 2 studies use super-resolution confocal imaging to measure CIE induced changes in lOFC
astrocyte morphology and synaptic proximity and single nuclei RNAseq approaches to reveal changes in lOFC
astrocyte and neuron gene expression. Aim 3 studies use a calcium exporter to blunt lOFC astrocyte calcium
signaling and determine how this affects CIE induced alterations in lOFC astrocyte physiology, morphology,
gene expression and voluntary ethanol consumption. Results from these studies will fill an important gap in our
understanding of the role of lOFC astrocytes in alcohol action and will generate novel and testable hypotheses
to support future studies.

Public health relevance
PROJECT NARRATIVE Identifying factors that underlie the development of excessive alcohol consumption is critical for developing effective treatments for alcohol use disorder. In this application, we focus on astrocytes in the orbitofrontal cortex (OFC) and how they contribute to changes in OFC neuron excitability and control over alcohol drinking.